2023 Germinal Stem Cell Biology GRC & GRS

GRC: GERMINAL STEM CELL BIOLOGY
Induction and Programming of the Germ Cell Lineage
Project Summary/Abstract
Germinal stem cells are the most potent known stem cell population, capable of giving rise to all embryonic and
extraembryonic cell types. Germ line stem cells were the first stem cell population recognized and, ever since,
have been the subject of intense research. They ultimately give rise to eggs and sperm and have the critical
responsibility of guarding the genome and transmitting it to the next generation. Researchers around the world
focus on understanding how germ line stem cells arise and how they are regulated at the genetic and epigenetic
levels to induce and maintain potency while safeguarding against the potential to differentiate as somatic cell
types or to form tumors. Lessons learned from this research have been instructive for all stem cell biology and
are crucial for understanding fertility and managing reproductive disorders. The pace of synthetic biology has
accelerated in recent years due to the advances in techniques such as single cell sequencing, epigenetic
analysis, and gene editing. New methods have allowed researchers to discover ways of efficiently inducing germ
line potency from a starting population of somatic cells and, more recently, of forming gonadal somatic lineages
from iPS cells that can potentially support germ cell development in mice, monkeys, and humans. These
discoveries advance the hope of producing gametes in vitro for applications in biomedicine such as infertility,
and applications in biotechnology such as species preservation and livestock management. This conference
will gather international scientists at the forefront of germ cell research with the goal of sharing the rapid
developments in the field among community members. This conference is focused on mammalian systems,
however vertebrate systems where recent advances have occurred are often included. We aim to make this
conference a forum for exchange among scientists interested in the basic biology of germinal stem cells and
those engaged in clinically relevant aspects of germ cell biology and fertility. Honoring the tradition of Gordon
Research Conferences, the meeting will be a venue to present unpublished data and cutting-edge advancements
in the field, followed by robust discussions. It will highlight emerging concepts and new research directions and
help establish collaborations across disciplines and across nations. Topics to be discussed include: specification
of the germ line, germ cell niches and signals, heterogeneity in the germ line, environment x epigenetic
programming in the germ line, metabolic regulation of germ cell development; in vitro development of germ cells
and fertility recovery; sex chromosomes and meiosis; mutation and aneuploidy in the germ line; RNA metabolism
and post-transcriptional control of germ cell development; and the bioethics of synthetic human embryology.

Public health relevance
Project Narrative The goal of the 2023 Germinal Stem Cell Biology GRC conference is to bring together leading scientists at the forefront of international research in the vertebrate germ cell field and to provide a forum for exchange between scientists interested in the basic biology of germinal stem cells, and scientists and clinicians engaged in clinically relevant aspects of these systems. This conference will enhance the exchange among scientists around the world. The meeting will include a Gordan Research Seminar (GRS) which will provide opportunities for trainees and junior investigators to present their research and enhance their career development through interactions with senior and other junior members of the field.